Utah Pediatric Clinical Pharmacology Training Program

Abstract: This is an initial T32 submission by the University of Utah Division of Clinical Pharmacology to the
NICHD-sponsored Clinical Pharmacology Training Network (CPTN). The goal of the CPTN training programs
is to ensure that a diverse and highly trained workforce is available in clinical pharmacology and therapeutics.
Pediatric and maternal pharmacologists are urgently needed because the majority of drugs prescribed to
children and pregnant and lactating individuals lack dosing information specific to these populations. The lack
of evidence-based dosing results in off-label prescribing and places these populations at risk for treatment
failures and toxicities. These outcomes can be avoided with innovative clinical drug studies. Design and
interpretation of these studies requires trained pediatric and maternal pharmacologists. Properly trained
pediatric and maternal clinical pharmacologists are indispensable for their ability to integrate basic and clinical
science including trial design, epidemiology, biostatistics, biomarker qualification and standardization; disease-
specific biomarker development; novel clinical trial design and endpoints; and bioinformatics. At present there
is a shortage of scientists who have formal training in pediatric and maternal clinical pharmacology. The goal of
the Utah Pediatric and Maternal Clinical Pharmacology T32 Fellowship Program is to develop clinician- and
PhD-scientists who will be leaders in the field of pediatric and maternal clinical pharmacology research. This
will be accomplished by providing training and experience in the methods and conduct of basic and clinical
drug research in the different phases of pediatric drug development and fostering interaction with pediatric
subspecialists to address deep knowledge gaps in pediatric therapeutics. We will leverage the resources of the
Division of Clinical Pharmacology in the Department of Pediatrics (expertise in pediatric clinical pharmacology),
the Department of Obstetrics and Gynecology (expertise in maternal pharmacology), the Department of
Population Health Sciences (expertise in pharmacoepidemiology), and the College of Pharmacy (expertise in
assay development and the mechanistic methods that inform clinical pharmacology studies). We have an
excellent team of 22 established and emerging mentors who will support up to 3 postdoctoral positions per
year. The T32 fellowship leverages the infrastructure of the existing American Board of Clinical Pharmacology-
accredited Utah Clinical Pharmacology Fellowship Program. The T32 fellowship will combine expert
mentorship with rigorous training in the principles of clinical pharmacology, quantitative skills, clinical trials,
regulatory affairs, and writing and presentation. Training will include a mix of didactic coursework and practical
training. Each fellow will have their own primary project and be integrated into multiple other projects. At the
end of the two-year training, each fellow will have answered an important clinical question in pediatric or
maternal pharmacology, have 5-10 publications, have submitted one grant, and will be ready to submit a
mentored K-level grant.

Public health relevance
The majority of drugs prescribed to children and pregnant and lactating individuals lack dosing information specific to these populations, placing these vulnerable populations at risk for treatment failures and toxicities. The Utah T32 Pediatric and Maternal Clinical Pharmacology Fellowship Training Program will develop clinician- and PhD-scientists who will be leaders in the field of pediatric and maternal clinical pharmacology research.